TECHNOLOGY TRANSFER-OPTICS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The technology transferred in Core IV relate to the following issues: 1) Details about how to build Diffuse Correlation Spectroscopy instrumentation and probes, 2) Details about how to build Diffuse Correlation Spectroscopy instrumentation and probes (focus on laser systems), 3) Diffuse optical tomography image reconstruction software/algorithms, 4) Details about how to build Laser Speckle Flowmetry and Diffuse Correlation Spectroscopy instrumentation, and 5) Diffuse optical tomography software.